IMMUNOPATHOLOGY OF OCULAR DISEASES IN HUMANS

Specimens from human ocular tissues with various diseases such as uveitis, conjunctival and corneal diseases, metabolic genetic diseases, and tumors were studied using immunohistochemical and in situ hybridization techniques as well as light and electron microscopic evaluation. In uveitis, immunocompetent cells and lymphokines are valuable in the reflection of clinical diagnosis, disease course, and prognosis. In non-uveitis conditions, alteration of cellular membrane surface markers and intracytoskeleton of the ocular resident cells may imply damage and abnormalities in these diseases. Elucidating the role of the relationships between infiltrating inflammatory or malignant cells and other resident cells in the clinical behavior of various diseases will increase our understanding of human ocular disorders.